Coordination of complex dynamics by DNA manipulating enzymes

Project Summary
My laboratory will use a combination of magnetic tweezers-based force and torque measurements, single
molecule fluorescence measurements, and computational methods to study the activity of two genome
maintenance systems: (1) the human transcription factor IIH (TFIIH) and (2) the type IA topoisomerase of
mycobacteria. Both of these systems require the coordinated movements of multiple components to
accomplish their functions. We will make use of two different single molecule methods to simultaneously
measure orthogonal degrees of freedom. Using this approach we will be able to follow complex protein-DNA
dynamics in real-time in order to better understand these systems. We will also use molecular dynamics
simulations to determine the molecular motions underpinning the experimental observations. TFIIH is a DNA
unwinding enzyme that plays a major role in two of the most important cellular functions, transcription of DNA
to RNA and repair of damaged DNA. Because of this dual function, TFIIH is a potential target for
chemotherapeutics. It has also been linked to human disorders of DNA repair. TFIIH is a large, multidomain
protein complex. The core TFIIH complex includes both a DNA helicase domain and a DNA translocase
domain. Evidence from biochemical studies and high resolution cryo-EM structures suggest that in the
nucleotide excision repair pathway, these domains work in concert to open a bubble in DNA. A major limitation
of such studies, however, is the inability to directly observe the active dynamics of the enzyme on the structure
of DNA. Over the next five years, we will develop and conduct simultaneous single molecule force and
fluorescence assays to observe TFIIH in action to understand how the helicase and translocase
domains coordinate their activities. Type IA topoisomerases are a class of enzyme that are found in virtually
all organisms. These enzymes remove excess supercoils from DNA to maintain genome integrity. While many
chemotherapy drugs and antibiotics target other topoisomerases, there are currently no drugs in use against
type IA topoisomerases, making them an important potential target for novel therapeutics. The type IA
topoisomerase of Mycobacterium tuberculosis has been identified as a potential target for antibiotics against
drug-resistant tuberculosis. Mycobacteria type IA topoisomerases contain unique C-terminal domains which
are required for passage of one strand of dsDNA through a protein-mediated DNA-gate in the other strand. The
details of this strand passage activity and its coupling to gate opening are unclear. We will use a combination
of single molecule force and fluorescence assays and molecular dynamics simulations to probe the
activity, conformational dynamics, and drug-response of mycobacteria type IA topoisomerases. Single
molecule methods offer the opportunity to understand the mechanisms of enzyme activity by following dynamic
molecular processes in real-time. Combining different single molecule methods will allow us to measure
different aspects of the enzyme-DNA interactions, deepening our understanding of these processes.

Public health relevance
Project Narrative The biomolecular processes responsible for maintaining the integrity of DNA often require the coordinated movements of multiple components. To fully understand such processes, it is necessary to probe multiple aspects of protein and DNA motion, ideally at the same time. This project would use a combination of single molecule force and fluorescence measurements, supplemented with computational simulations, to explore the complex behavior of two systems related to genome maintenance and DNA repair: human transcription factor IIH and the type IA topoisomerases of mycobacteria.